TR2 nuclear receptor in vitamin A signaling

Project Summary
The grant “TR2 nuclear receptor in vitamin A signaling” (since 08/01/99) was initiated from studying retinoic
acid (RA) signaling using an embryonic stem cell-specific orphan receptor TR2’s (NR2C1) as a model to
understand RA’s action in developmental regulation. The long-term goal is to comprehensively understand RA
signaling pathways in health and diseases. Results first established RA’s activity in chromatin-remodeling via
RA receptors (RARs), Retinoid X receptors (RXRs) and TR2. In 2008, we reported a then-mysterious effect of
RA that did not involve RAR/RXR - it occurred rapidly in the cytoplasm to modulate ERK signaling, and thus
was proposed as “non-canonical”. Previous proposal (05/1/2017-04/30/2022) aimed to i) identify the mediator
of this non-canonical activity of RA in modulating ERK signaling and synthetic RA-like ligands specific to this
pathway, and ii) determine the physiological relevance. Results (published in 14 papers) have established
Cellular Retinoic Acid Binding Protein 1 (CRABP1) as the mediator, characterized RA-CRABP1-RAF-MEK-
ERK signaling pathway and CRABP1 ligands specific to this pathway, and revealed physiological relevance in
maintaining neuron stem cell pool, adiposity and inflammation, all involving CRABP1-ERK regulation. Recently,
a second signaling pathway also directly modulated by CRABP1 was uncovered, calcium/calmodulin-
dependent protein kinase II (CaMKII), but in a different physiological context - excitable cells requiring tight
regulation of CaMKII such as motor neurons (MNs) and cardiomyocytes. The principal hypothesis is, RA-
CRABP1 signalosomes form in specific cellular environments to provide timely (rapid) modulatory
mechanisms ensuring homeostatic propagation of intracellular signals that are critical to the
survival/function of the cells. Pertinent to CRABP1-CaMKII, our recent data show that CRABP1 is highly
expressed in MNs, and CRABP1 knockout (CKO) mice spontaneously develop age-dependent motor deficit
resembling motor symptoms of MN degenerative disease Amyotrophic Lateral Sclerosis (ALS), preceded by
morphological, structural, and functional deterioration of MNs and neuromuscular junctions (NMJs). We thus
engineered a sequenced MN-muscle co-differentiation system on custom-fabricated Hydrogel to generate an
in vitro, functional 3D NMJ model for molecular studies. Two aims are to i) dissect molecular mechanisms
of RA-CRABP1-CaMKII signalsome action in NMJ and identify CRABP1 ligands specific to this
pathway, and ii) determine the physiological action of RA-CRABP1-CaMKII signaling and its disease
relevance/therapeutic applications. Aim 1 will employ engineered 3D NMJ model to dissect physiologically
relevant signaling pathways and molecular mechanisms. Aim 2 will distinguish “non-canonical” from
“canonical” activity of RA by comparing CRABP1 ligands and RA in maintaining healthy NMJs, and determine
the therapeutic potential of targeting CRABP1 to improve motor function.

Public health relevance
Project Narrative All-trans Retinoic acid (atRA), the biologically active form of Vitamin A, acts to regulate genome program by activating RA receptors, known as canonical activity, and to elicits non-canonical activities recently identified in multiple physiological processes via CRABP1. The long-term goal of this project is to comprehensively understand how vitamin A (atRA) affects health and diseases. The current proposal focuses on the non- canonical atRA signaling mediated by Crabp1 to modulate CaMKII signaling in excitable cells such as motor neurons, which is essential to the health of neural muscular junction and motor function.